Expand Standardized Statewide Data System Capture of Inventory and Inspection Results in Support of the Voluntary National Retail Food Regulatory Program Standards in Colorado

Project Summary/Abstract Expand Standardized Statewide Data System Capture of Inventory and Inspection Results in Support of the Voluntary National Retail Food Regulatory Program Standards in Colorado The intent of this cooperative agreement award would be to utilize this funding opportunity to increase compatibility of the multiple data systems that are currently utilized by Colorado’s local public health agencies. Of the 63 counties in Colorado, 45 currently utilize CDPHE’s uniform data system. In an effort to expand uniformity, the goal of this cooperative agreement is to provide the resources to nine local agencies to migrate to the statewide data platform. This project will improve conformance with multiple Retail Food Regulatory Program Standards, including Standards 1, 3, 4, 6 and 8. Over the duration of this grant cycle, nine county data systems will migrate their programs into the CDPHE data system. The speed and order of local agencies migrating into the system will be determined by the pace at which those agencies can prepare facility data into formats suitable for the transition and maintain the stability of their current data systems. Ultimately, in addition to uniformity, this resource provided to our local regulatory partners allow them the ability to direct their local funding resources to their non-funded needs to support their community.

Public health relevance
Project Narrative Expand Standardized Statewide Data System Capture of Inventory and Inspection Results in Support of the Voluntary National Retail Food Regulatory Program Standards in Colorado In 2019, the Colorado Department of Public Health and Environment’s Division of Environmental Health and Sustainability (CDPHE-DEHS) transitioned 63 counties in Colorado to the most current FDA Food Code available. In 2020, the State has implemented a new, progressive methodology for enforcement, which takes into consideration not only the severity of the identified violation but also prevalence. It is the intent of the (CDPHE-DEHS) to use this funding opportunity to increase the compatibility of the multiple data systems that are currently utilized by Colorado’s local public health agencies. Of the 63 counties in Colorado, 45 currently utilize CDPHE’s uniform data system to manage inventories, calculate risk-based inspection frequencies, capture inspection results, and manage enforcement re-inspections. CDPHE-DEHS has an opportunity to bring that uniformity to an additional nine counties that this grant funding will afford by funding their transition into the CDPHE data collection system. This is just one step in our effort to expand uniformity among the local regulatory programs responsible for food protection in Colorado. Our ultimate goal is to assist all 18 counties that currently use disparate data systems in a migration to the statewide data platform. The resources made available through this grant will move the program significantly closer to the goal of 100% participation. The resources provided through this project will improve conformance with multiple Retail Food Regulatory Program Standards. Colorado has completed a rulemaking to adopt the 2013 FDA Model Food Code and Supplement as the Colorado regulation and passed statutory authority for a new enforcement model. Bringing nine new counties into the uniform CDPHE Retail Food Program data system that currently supports the FDA Food Code and the enforcement changes will increase uniformity within these local agencies and will improve their conformance with Standards 1 and 4. The CDPHE data system for enforcement has incorporated a three-tier system to assess the severity and prevalence of violations, risk categorization for food establishments and automatically calculates inspection frequencies based on risk. The data system also automatically schedules and tracks re-inspections and enforcement activities. These capabilities of the data system will improve conformance with Standards 3 and 6 once these nine counties are migrated into this system. These grant resources allow CDPHE to support the costs of implementing and maintaining the Retail Food data system at little or no costs to local agencies. By providing this to our local partners, this allows for them to increase the availability of local revenues to support their other non-funded program needs therefore improving conformance with Standard 8. Over the duration of this grant cycle, nine counties will migrate from their current data systems into conformance with the CDPHE uniform data system. The pace and order of local agencies migrating into the system will be determined by the pace at which those agencies can prepare facility data into formats suitable for migration and the stability of their current data systems. This project anticipates that all nine proposed county systems will be migrated into the CDPHE data system during the project period